Photonic Crystal Surfaces for Label-Free Detection and Fluorescence Amplification

DESCRIPTION (provided by applicant): This revision application is submitted in response to Notice Number NOT-OD-09-058 (Notice Title: NIH Announces the availability of Recovery Act Funds for Competitive Revision Applications). The revision application adds two new Specific Aims to a previously funded R01 application for Funding Opportunity PAR 07 070, entitled "Photonic Crystal Surfaces for Label-Free Detection and Fluorescence Amplification: Application to DNA Microarrays," by B.T. Cunningham, L. Vodkin, and G. Bollero. The original grant (PHS 1R01 GM086382) includes funding for 1/1/09 through 12/31/12. The revision adds a new PI to the project - Dr. Richard Zangar from Pacific Northwest National Laboratory (PNNL) to include nationally recognized expertise in protein microarrays. DNA and protein microarrays are capable of simultaneously evaluating the relative expression levels of thousands of genes or dozens of cancer biomarkers, and have developed rapidly since their initial introduction. As a result, microarrays are now one of the most preferred technologies for identifying early genetic or expressed protein biomarkers of toxicity and disease. The outcome of microarray studies can be affected by many technical and instrumental factors, resulting in major criticism regarding lack of reproducibility and accuracy of the derived data. Although fluorescent dyes, surface chemistries, spotting robots, hybridization chambers, detection instruments, and data analysis tools have all undergone substantial development and refinement, the microarray substrate itself remains as a simple glass surface. In this proposal, we describe how replacement of the glass surface with a special-purpose optical transducer can provide quality control information on the interspot and intraspot density of microarray spots that is currently completely lacking from microarray analysis, while simultaneously amplifying the intensity of fluorescent labels used to quantify hybridized DNA or protein. By providing information on spot variability, (representing a major source of error in microarray analysis), while at the same time increasing the signal-to-noise ratio for detection of weakly expressed genes (where microarray platforms currently face a disadvantage compared to other quantitative gene expression platforms) or protein biomarkers in serum at concentrations <1 ng/ml, the proposed project represents a fundamental advance in microarray technology. The optical transducer used to provide these features is a 2-dimensional photonic crystal (PC) surface that is designed to provide optical resonances that enable high resolution label-free imaging detection of deposited microarray spots and up to 550x enhanced detection sensitivity of commonly used microarray fluorescent dyes. The PC is fabricated by a large-area nanoreplica molding process on plastic substrates that are attached to standard glass microscope slides for compatibility with existing spotting robots, hybridization chambers, and detection instruments. Recently, large area PC surfaces have been developed by the Cunningham Group at Illinois as multifunctional optical transducers that can be designed to produce narrow-wavelength electromagnetic resonances at any desired wavelength, featuring high intensity fields that extend evanescently into the media on the PC surface. The interaction of the optical resonance with adsorbed biomolecules results in a highly localized shift of the resonant wavelength that is used to quantify the density of adsorbed material without the use of fluorescent labels, enabling label-free images of deposited microarray spots to be measured with 4 μm spatial resolution over a PC comprising the entire surface of a conventional microarray slide. A PC surface may also be designed so that the optical resonance coincides with the wavelength of a laser used to excite a fluorescent dye, thereby increasing the fluorescent output intensity relative to the intensity that would occur on an ordinary glass microarray slide, using an effect called Enhanced Fluorescence (EF). The EF effect has been shown to result in ~50x increase in the detected fluorescence signal using commercially available microarray laser scanning instruments, but can be further enhanced when the PC is designed to also incorporate an optical resonance at the emission wavelength of the fluorophore, resulting in an additional 10x gain in sensitivity. In the proposed additional specific aims, we plan for the first time to apply 2-dimensional PC surfaces that incorporate optical resonances for both label-free detection and EF to protein microarrays. The label-free resonance will be utilized to quantify the density variability of deposited protein capture spots, thereby providing a quality-control tool that is not currently available to researchers using spotted arrays. The labelfree images of spots will be used to quantify interspot and intraspot density variability, providing information that will be used to eliminate defective spots from further analysis or as a means for normalizing the detected signal from subsequent fluorescent measurements. The EF resonance will be applied to enhance the output of Cy5-labeled hybridized protein biomarkers in serum, enabling biomarker detection and quantification to be conducted with lower sample concentrations and the ability to observe protein expression at lower levels than has previously been possible. PUBLIC HEALTH RELEVANCE: The proposed project seeks to develop a technology platform for providing high-sensitivity label-free detection of biomolecules and substantial amplification of fluorescence output on large-area, plastic based nanostructured surfaces called "photonic crystals." The goal is to incorporate photonic crystal surfaces into DNA and protein microarray slides to provide label-free quality control of array spots and the ability to more easily detect and identify genes with low expression levels or protein biomarkers for cancer at low concentrations in serum. The project is relevant for the development of gene-based and protein-based diagnostic tests that are accurate, reliable, and able to detect analytes at low concentration.

Public health relevance
The proposed project seeks to develop a technology platform for providing high- sensitivity label-free detection of biomolecules and substantial amplification of fluorescence output on large-area, plastic based nanostructured surfaces called "photonic crystals." The goal is to incorporate photonic crystal surfaces into DNA and protein microarray slides to provide label-free quality control of array spots and the ability to more easily detect and identify genes with low expression levels or protein biomarkers for cancer at low concentrations in serum. The project is relevant for the development of gene-based and protein-based diagnostic tests that are accurate, reliable, and able to detect analytes at low concentration.